Translational Clinical Research Fellowship on Substance Use Disorders

Project Summary/Abstract
Advances in basic science and pre-clinical research have significantly increased our understanding of the
neurobiological underpinnings of addiction. However, there is a need to train investigators who can move
these discoveries from the lab to the clinic. Our T32 fellowship meets this need, by training clinician-
scientists dedicated to translational research in substance use disorders (SUDs). This renewal
application will continue our postdoctoral program which is specifically designed for physicians and
clinical psychologists. The main objective of this program, now in its 29th year, is to provide both the
research skills and clinical expertise necessary to design and carry out independent, translational
SUD treatment research. Our program has graduated 25 MDs/DOs, 3 MD/PhDs and 5 PhDs in the past
15 years and is currently training 4 MDs and 2 PhDs. Our graduates have obtained K and/or R awards,
engage in team-based research, or attain academic teaching or governmental research-related positions.
To provide sufficient support to ensure their success, our trainees are given 2 years of training, and a
third year is offered to those making excellent progress but who need more time to obtain independent
funding. Our well-funded and diverse pool of senior faculty preceptors have extensive track-records in
training physicians and psychologists. Further, we have a growing cadre of junior faculty to provide
additional support. In this competing application we are requesting 5 years of funding for 6
postdoctoral fellows to be enrolled each year. Our training includes: 1) Didactic coursework, including
weekly seminars that provide a comprehensive overview of the SUD field; instruction on rigor and
reproducibility and data science; courses in statistics and research methodology; a monthly workshop on
emerging issues in addiction; a 2x/month seminar where fellows and faculty present their latest findings
or developing projects; a monthly invited speaker’s seminar; and ongoing instruction on the ethical
conduct of clinical research; 2) Research apprenticeship where each fellow works under the close
supervision of primary and secondary senior mentors as well as a junior/mid-career investigator; 3)
Clinical experience in the major modalities used to treat SUDs; and 4) Development of teaching skills
where each fellow engages in seminars with medical students and housestaff and present research
findings at journal clubs and scientific meetings. While our traditional foci of training remain clinical trials
and human behavioral pharmacology, new opportunities such as novel therapeutics, implementation
science, and clinical effectiveness research (using electronic health records/big data) are available to our
fellows as they choose their own career paths as future clinician-scientists.

Public health relevance
Project Narrative: Substance use disorders (SUDs) remain a significant public health problem that requires more effective treatment interventions. A cadre of clinical researchers is needed to develop novel treatment interventions for SUDs, often through translational research, to better understand who best responds to these interventions, and ways to best promote the implementation of these interventions. Our long- standing program has been at the forefront of training early career investigators and through continued support, our program hopes to continue to train the next generation of clinical investigators who will eventually become leaders in the substance use disorder field.